MECHANISMS OF OXIDATIVE INJURY IN NEURONS AND ASTROCYTES

Hypoxia and hyperoxia decrease dehydrogenase (LDH) and protein content, cause cell edema, and disrupt cell membranes of primary cultures of astrocytes. Fructose-1, 6-diphosphate (FDP) + glucose (GLc) prevents these changes, but FDP or Glc alone does not. During hypoxia, Na+-K+ ATP-ase activity increases when FDP + Glc is present; it decreases with Glc or FDP alone. We postulate that the protective effects of FDP are either due to increased metabolism and maintenance of normal cellular ion homeostasis or to effects on oxygen free radical production and cell membrane destruction. To test our hypotheses, we will determine whether FDP increases metabolism and ATP content of hypoxic and hyperoxic astrocytes and neurons, whether FDP maintains normal intracellular concentrations of ions, whether FDP prevents cell edema, and whether FDP maintains membrane integrity and function. To determine whether FDP prevents the effects of oxygen free radicals on normoxic and hyperoxic cells, we will determine whether oxygen free radical production increases, whether membrane is altered. Membrane fatty acid composition will also be determined. These studies will provide new information about the effects of hypoxia and hyperoxia on astrocytes and neurons and about the mechanism by which FDP prevents detrimental effects of low and high oxygen. This information will increase our understanding of how cells are injured by abnormal oxygen states and may lead to new methods of brain protection.